DNA Damage & DNA Replication: a Complex Relationship

“This is from the Parent Award. No changes.”
Our overarching goals are: i. to define the mechanism(s) of ATM activation by the
Mre11 complex; ii. to define the role(s) of the Mre11 complex in DNA replication; iii. To
define the role(s) of the Mre11 complex in response to DNA replication stress. As part
of the emphasis of DNA replication stress, our focus includes RTEL1 which acts to
mitigate replication stress at the telomere. A combination of yeast and mouse genetics,
biochemistry, and structural biology are employed to address these issues. Our
previous work on these topics led to substantial scientific progress and insight regarding
processes relevant to human health. Specific areas of inquiry are:
· Genetic screens in yeast and mining of cancer genomic data revealed separation
of function Rad50 mutations that affect ATM dependent DNA damage signaling
without affecting the DNA repair functions of the Mre11 complex. These
mutations constitute a resource for deciphering the mechanism by which the
Mre11 complex activates the ATM kinase to initiate DNA damage signaling.
· We have modeled three recurrent tumor borne mutations in mice that were
confirmed to be hypomorphic for ATM activation but proficient in DNA repair.
These animal models offer a unique opportunity to delineate Mre11 complex-
dependent ATM functions.
· We have identified factors that function at the DNA replication fork in a manner
that depends on the Mre11 complex. An important focus of our laboratory is to
understand the functional role(s) of those factors. Defects in factors that promote
accurate DNA replication are highly correlated with human disease, and so
understanding this fundamental process is an important priority in our work.
· Whereas the Mre11 complex functions at the replication fork, RTEL1 is a
helicase that promotes accurate replication of telomeric DNA. We have
discovered that RTEL1 influences the abundance and disposition of a long non
coding RNA, called TERRA, that is transcribed from the subtelomeric regions of
all eukaryotes. Our goal in this aspect of our work is two fold. First, to
understand the role of RTEL1 in maintaining telomere stability. Second, to use
that information to shed light on the function of TERRA, which is a long standing
question.

Public health relevance
Genome instability is a hallmark of cancer, and defects in the DNA damage response, which is required for the maintenance of genome stability are associated with cancer as well as human syndromes associated with reproductive, developmental and neurological defects. We address the functions of the Mre11 complex and RTEL1, both of which have been implicated in human chromosome instability syndromes associated with increased risk of malignancy, bone marrow failure, developmental abnormalities. The experiments described examine the roles of these proteins in the DNA damage response, and have the potential to provide insights regarding the mechanisms underlying human disease including cancer and immune deficiency.